Impact of the Gut Microbiome on Astrocyte Barrier Function

Project Summary/Abstract
This proposes a comprehensive 5-year physician scientist career development plan for Dr. Stephanie Tankou.
Dr. Tankou completed her postdoctoral fellowship training in Multiple Sclerosis at the Brigham and Women’s
Hospital. During her fellowship years, she was involved in several preclinical and clinical studies investigating
the role of the gut microbiome in multiple sclerosis (MS) and its mouse model experimental autoimmune
encephalomyelitis (EAE). Since joining Mount Sinai as a tenure track faculty, she has been conducting several
studies to investigate the effect of vancomycin on neuroinflammation in EAE mice. Studies from her laboratory
revealed that vancomycin is a potent modulator of the gut-brain axis and they also identified 50 gut commensals
that regulate neuroinflammation in EAE mice. This work has been recently accepted for publication in
Microbiome and Dr. Tankou is the corresponding and senior author. The application builds on Dr. Tankou’s
preliminary data supporting a key role for butyrate-producing bacteria in regulating astrocyte function and is
structured to transition Dr. Tankou from trainee to fully independent investigator by leveraging intellectual and
material resources at the Icahn School of Medicine at Mount Sinai. Dr. Scott Russo has mentored successful
trainees and will guide Dr. Tankou throughout her training. Dr. Russo is an established investigator and
recognized leader in blood brain barrier permeability in the context of neuropsychiatric diseases. An advisory
committee composed of highly regarded principal investigators in glial cell research, gut-brain axis and the role
of the gut microbiome in immune mediated diseases will provide additional guidance. Dr. Tankou’s career
development plan is comprehensive, including frequent meetings, specific relevant coursework, and
departmental support centered on mentoring early career investigators. She has and will continue to attend
seminars as well as national and international conferences where she will present her research, establish
collaborations, and learn of recent advances in the field. Dr. Tankou’s research utilizes cutting-edge approaches
to advance understanding of the role of the gut microbiota on astrocyte barrier function. She proposes to identify
communities of gut microbes and their metabolites that regulate astrocyte barrier function and their impact on
central nervous system (CNS) inflammation. Dr. Tankou preliminary data have demonstrated that butyrate-
producing bacteria as well as butyrate modulate astrocyte barrier function via induction of astrocytic claudin-4.
In the first specific aim, experiments will be conducted to identify human gut derived bacteria and gut microbiota
derived metabolites that modulate astrocytic CLDN4 expression. The second aim will examine the effect of
butyrate on (1) astrocytic CLDN4 expression, (2) immune cell trafficking across the glia limitans and (3) CNS
inflammation in EAE mice. The Icahn School of Medicine has demonstrated commitment to Dr. Tankou’s career
with a 75% protected faculty position to conduct research. She hopes to develop innovative microbiome-based
approaches to target neuroinflammation and neurodegeneration in MS.

Public health relevance
Project Narrative: Despite significant advances in multiple sclerosis (MS) therapeutics, current treatments for MS are expensive, complicated to manage and suboptimal in that many patients continue to have breakthrough disease activity and progression, as well as expected adverse effects of medications that suppress the immune system. Disease progression in MS is mediated by activation of astrocyte and microglia, yet none of the currently approved FDA drugs for the treatment of MS effectively target these glial cells. This project aims at identifying gut microbiota and gut microbiota derived metabolites that regulate astrocytes function and their impact on neuroinflammation with the ultimate goal to develop the first microbiome-based therapies for the prevention and treatment of MS.